Center Core Grant for Vision Research

Project Summary – Overall Center Core
The overarching goal of the Center Core Grant for Vision Research is to support, strengthen and broaden
basic and translational vision science research at the University of Southern California. The Center Core will
provide shared resources accessible to a group of 23 outstanding investigators, dedicated to elucidating
mechanisms, diagnosis, and treatment of ocular diseases. Currently, these participating investigators hold a
total of 28 NIH-funded research grants, consisting of 20 research grants from NEI (including, 13 qualifying R01
grants). The Center Core will support 3 highly integrated Resource Cores: Ophthalmic Therapeutics
Engineering Core, Animal Models and In Vivo Imaging Core, and Cell and Tissue Imaging Core. These Cores
will offer exceptional facilities, instrumentation and expertise that are essential resources to enhance and
expand the research programs of participating investigators, aid established investigators in pursuing research
in new emerging fields, and assist new investigators in developing vision research projects. The Center Core
will also coordinate and integrate Core activities, promote utilization of innovative emerging technologies, and
facilitate collaborative inter-disciplinary vision research. The Center Core will serve as a cornerstone for
conduct of impactful basic and translational vision research focused on advancing knowledge of the biology
and pathophysiology of the visual system and development of novel therapeutic approaches for vision
impairment.

Public health relevance
Project Narrative The Center Core Grant for Vision Research will provide shared resources accessible to a group of independently-funded investigators to enhance their research capabilities and productivity. It will also create an environment conducive to collaborative scientific interactions and inter-disciplinary vision science research focused on advancing knowledge of the visual system and treatments for vision impairment.